Computational Methods for Precise Holographic Control and Mapping of Neural Circuits

PROJECT ABSTRACT
Precisely mapping the structure of synaptic connectivity offers a pathway to understanding the function of
neural circuits and how they go awry in neurological disease. Holographic optogenetics has recently emerged
as a revolutionary technology capable of optically probing the synaptic structure and function of neural circuits
through the stimulation of neurons with near single-cell precision. However, despite its success, this technology
is currently greatly underutilized due to a lack of computational methods capable of modeling these complex
experiments and interpreting the data they generate. Thus, there is a need for new computational methods to
maximize the scientific impact of holographic optogenetics in neuroscience research.
In recent work, I have created a machine learning algorithm for inferring monosynaptic connectivity from
holographic stimulation of specifically targeted populations of neurons. This algorithm increased the rate of in
vitro monosynaptic connectivity mapping by more than an order of magnitude over existing approaches using
optogenetic stimulation, demonstrating the transformative effect that computational methods can have in this
scientific domain. Building on this advance, I now propose to develop a set of computational methods enabling
holographic control and mapping of neural circuits in vivo and at unprecedented detail, scale, and precision.
In Aim 1 of this proposal, I will develop a real-time target optimization algorithm to select holographic
stimulation parameters that eliminate the unintended activation of non-target neurons when attempting to
probe the connectivity or function of neural circuits (K99). In Aim 2, I will extend my earlier connectivity
mapping inference approach by using calcium imaging to discriminate the presynaptic origin of postsynaptic
responses at extremely fine detail (K99/R00). Finally, in Aim 3, I will develop a computational approach that
leverages voltage imaging to all-optically map tens of thousands of potential recurrent connections between
hundreds of neurons (R00). Together, these aims provide practical tools enabling high-throughput collection of
large-scale maps of synaptic connectivity within individual experiments. Using these tools to probe the
structure and function of neural circuits could ultimately shed light on the etiology of neurological diseases.
During the K99 phase, this work will be conducted at the Zuckerman Mind Brain Behavior Institute at Columbia
University, where I will receive scientific training in computational neuroscience under Dr. Liam Paninski, a
leading authority in computational methods for neural data. Additionally, I will receive training in experimental
neuroscience from Drs. Hillel Adesnik and Adam Cohen, who are experts in holographic optogenetics and
voltage imaging. Their combined scientific expertise and impressive track record of transitioning postdoctoral
scientists to faculty positions make them the ideal mentorship team for my goal of becoming an independent
group leader working on computational methods for the optical interrogation of neural circuits.

Public health relevance
PROJECT NARRATIVE Pathological synaptic connectivity is implicated in a number of neurological disorders, including devastating neurodegenerative diseases such as Alzheimer's disease. Tools for characterizing the function and synaptic structure of neural circuits in both the healthy and diseased brain are therefore critical for understanding the etiology of such neurological disorders. This proposal thus focuses on developing computational methods for holographic optogenetics to enable large-scale yet precise control and monosynaptic mapping of neural circuits.